Optimizing Patient-Centered Routine Care at a Distance for Veterans with Chronic Conditions

Background: As a result of COVID-19, the VA has undergone a sizable transition to Care at a Distance in
order to ensure the safe delivery of services. Components encompass expanded telehealth, distancing
measures at routine face to face visits, and other practice changes. How Veterans with chronic conditions who
regularly use VA healthcare experience these changes is unknown. This 18-month pilot study assesses a
mixed methods approach to describe Care at a Distance for older, chronically ill Veterans, how service
changes are experienced by Veterans, and how the experiences affect health management and outcomes.
Significance/Impact: The unprecedented impact of COVID-19 provides an opportunity to advance novel
Veteran-centered mixed methods to understand the pandemic’s effects on Veteran healthcare. Investigations
can identify and test out Veteran-centered system improvements that support preparedness for future
emergencies. This study aligns with VA’s strategic goals and objectives for FY2018-2024 to promote ‘customer
service,’ and HSR&D’s scientific priorities to improve telehealth’s effectiveness, and to use primary care to
optimize complex chronic disease management. It also aligns with ongoing activities in the Veterans
Experience Office using journey mapping to understand Veteran experiences of VA care. Innovation: The
proposed mixed methods pilot study is interdisciplinary, using novel methods in VA studies. By drawing upon
theories and methods of medical anthropology and health services research, the pilot study is positioned to
produce deep and actionable knowledge about COVID-19’s impact on Veterans and their care. Specific Aims:
Aim 1: Describe components of Care at a Distance, to inform adapting an experience-based journey mapping
template, which will describe how Care at a Distance affects the healthcare experiences of older Veterans with
comorbidities, and their health outcomes. Aim 2: Test the feasibility and acceptability, and conduct an analysis,
of embedding experienced-based journey mapping within in-depth qualitative interviews to describe Care at a
Distance for older Veterans with comorbidities, and their routine care providers. Aim 3: Assess the utility of the
mixed methods techniques to examine relationships among service changes, Veteran experiences, and health
outcomes, incorporating chart review as a comparative and triangulating data source. Methods: The study
uses a sequential design carried out at the James J. Peters VA in Bronx, NY and VA Hudson Valley Health
Care in upstate, New York. In Aim 1, a documents analysis of VA Care at a Distance changes will be
conducted to refine an inventory of components, key features, and their implementation. The inventory will
inform an adapted experience-based journey map template and interview topic guide, and a medical chart
analysis. In Aim 2, 40 Veterans will be recruited who are 65+ years old with two or more comorbidities (one
being HIV or diabetes) and eligible for enrollment in the GeriPact, or HIV clinic. Interviews will use the
experience-based survey mapping template to document service encounters and experiences before COVID-
19 (prior to March 2020), in the initial phase (March-May 2020), and during the Moving Forward period (June
2020-time of study). A follow-up interview will discuss feasibility and acceptability of mapping. 12 provider
interviews will be conducted about implementation and Veteran experiences of Care at a Distance, and the
feasibility of journey mapping. We will analyze for feasibility and acceptability, and conduct a qualitative
thematic and process analysis. In Aim 3, a chart review will be performed to examine the record of health use
and outcomes, and a comparative analysis will be performed between charts and the maps. Implementation/
Next Steps: Findings will be used to develop an IIR research proposal to: 1) describe Care at a Distance
impact across VA facilities; and 2) test out and evaluate interventions to improve care for Veterans, particularly
those aging with chronic health conditions. The VA Veteran Experience Office will partner on this study, and
continuous Veteran input will be sought.

Public health relevance
A large number of aging Veterans have several co-occurring health challenges, and routinely access VA services to manage their chronic health conditions. As a result of COVID-19, the VA has undergone a sizable transition to Care at a Distance, including expanding telehealth and practicing new distancing measures at routine face to face visits. How chronically ill Veterans experience these changes may influence their healthcare access and use of care, and health outcomes, particularly for those needing regular care. The proposed 18-month pilot study assesses a mixed methods approach incorporating Veteran experience-based journey mapping, to describe Care at a Distance and its impact on older, chronically ill Veterans’ health management and outcomes. Findings from this study will be used to develop a larger IIR research proposal to describe Care at a Distance across the VA system, and test out and evaluate interventions to improve care for all Veterans, particularly those aging with chronic health conditions.